Staging primary tauopathies with tau proteoforms

Project summary
Recent development in biomarker assays measuring amyloid beta and tau for Alzheimer’s disease (AD) and an
accelerated approval of anti-amyloid antibody, Lecanemab, defined a new era of AD research. However, there
are no specific fluid or imaging biomarkers for primary tauopathies including progressive supranuclear palsy
(PSP), corticobasal degeneration (CBD), and frontotemporal lobar degeneration (FTLD), making clinical trial
designs challenging. We have recently identified specific forms of tau protein in cerebrospinal fluid (CSF) that
reflect brain tau pathology and can identify subsets of primary tauopathies from healthy control groups and other
tauopathies. In this study, we propose to define when and which tau proteoforms change during disease
progression in familial and sporadic primary tauopathies. If successful, this study will facilitate accurate diagnosis
of primary tauopathies, determining clinical trial eligibility, evaluating drug efficacies, and developing treatment
based on underlying neuropathology in primary tauopathies. If successful, this study will start to realize personal
medicine for primary tauopathies and bridge the knowledge gap between AD research.

Public health relevance
Project narrative Primary tauopathies have no fluid or imaging biomarkers to track the disease during life. We will define when and which forms of tau proteins change during disease progression in familial and sporadic primary tauopathies. If we find primary tauopathy biomarkers that can stage the disease, it can help with early diagnoses and clinical trial designs.